Career Enhancement Program

Career Enhancement Program - SUMMARY/ABSTRACT
The central goal of the Career Enhancement Program (CEP) is to use the resources at the MD Anderson
Cancer Center to train exceptional young investigators in the early detection, prevention, and treatment of
hepatocellular carcinoma (HCC), with the hope that their research will reduce the mortality from this disease.
To achieve this goal, the CEP will provide two annual awards of $50,000 each, to two individuals for a two
years period, funded from the SPORE and matching funds from MD Anderson. Over the five years of the grant,
we expect to mentor up to six investigators. The intent of each CEP award is to prepare the selected scientists
to become international leaders in academic research relevant to HCC. The most promising young
investigators will be identified, mentored through an individualized clinical and laboratory development plan,
trained in grant and manuscript writing and in developing leadership skills. Awardees will be required to attend
all SPORE meetings and one national meeting where they can interact with liver cancer scholars and HCC
SPORE leaders. Awardees will also be required to present their research at the annual SPORE conference
and, if possible, to submit the results of their project for publication. Past awardees will be invited to all SPORE
events and encouraged to apply for funding in the area of research developed under the CEP and to keep
seeking advice from the SPORE leaders to further develop their careers. The CEP will be led by Drs. Michelle
Barton and James Yao, who together bring to the program a large breadth of expertise and wide network of
collaborators, and who are both recognized as outstanding role models and effective mentors.

Public health relevance
Career Enhancement Program - NARRATIVE The Career Enhancement Program is designed to foster the careers of young faculty members who want to become leaders in hepatocellular carcinoma translational research. The program will provide awardees with two years of individualized career development with both a clinical and a laboratory mentor, plus a mentoring team who will monitor the success of the awardees through a process of regular evaluation. The development plan will include instruction in grant and manuscript writing, leadership training, and participation in national meetings.